Structural characterization of MCE mediated lipid transport across the Mycobacterial cell envelope

PROJECT SUMMARY / ABSTRACT:
The cell envelope of Mycobacterium tuberculosis (Mtb) serves an important role as protection against
common antimicrobials and host cell defenses, but also a barrier through which Mtb must transport host
derived nutrients. The MCE protein family (originally implicated in Mammalian Cell Entry) is nearly ubiquitous in
double-membraned bacteria, and MCE proteins are now believed to act as transporters that facilitate lipid
movement between the inner and outer membranes. While Mtb MCE proteins are critical for virulence, their
mechanism in Mtb remains unclear. Due to Mtb’s distinct cell envelope Mtb MCE proteins likely adopt a unique
architecture to mediate transport. In addition, throughout the course of Mtb infection MCE transporters are
believed to be differentially expressed by MCE transcriptional regulators (MceRs). This suggests that
environmental sensing in Mycobacteria in turn alters transcription of the mce operons. Using structural biology,
biochemistry, and genetic complementation assays, I will provide the first glimpse into the architecture of Mtb
Mce protein systems and elucidate how MceRs interact with their operator sequences at the molecular level to
regulate mce operons. To do so I propose the following aims: (Aim 1) structure determination of the Mce4 lipid
transport system from Mycobacterium smegmatis and (Aim 2) structural characterization and DNA-binding
specificity of MceRs. My work will provide the first glimpse at the architecture of the M. smegmatis Mce4
transporter system, as well as the molecular mechanisms of MceR mediated mce operon regulation, which
may shed light on the mechanisms of cell envelope maintenance in Mtb and provide a novel target for
therapeutics.

Public health relevance
PROJECT NARRATIVE: Mycobacterium tuberculosis is the leading cause of death due to infectious disease worldwide. Mammalian cell entry (Mce) proteins are established virulence factors in Mtb implicated in hydrophobic molecule transport. Understanding the architecture of the Mce4 protein complex and the regulation of mce operons in Mtb will improve our understanding of how these transporters function in Mtb, and ultimately MCE complexes may serve as a target for the design of novel therapeutics.